Molecular Determinants of MG53 in Heart Structure and Function

PROJECT SUMMARY
Heart failure, measured at the subcellular level, is the result of impaired cardiomyocyte excitation-contraction
(E-C) coupling. One key structural component of E–C coupling is the myocyte transverse (T)-tubule system. T-
tubules play an essential role in coordinating membrane excitation with muscle contraction by facilitating the
synchronized release of Ca2+ from the sarcoplasmic reticulum. Our group, as well as those of others, have
provided strong evidence that failing myocytes from patients and animal models are characterized by a
degenerated and disorganized T-tubule system resulting in impaired intracellular Ca2+ dynamics and
myofilament contraction. The long-term goal of our research is to discern and take advantage of the
fundamental mechanisms underlying T-tubule remodeling processes in heart disease toward restoring T-tubule
integrity and slowing, if not reversing, heart failure progression. We have identified Mitsugumin 53
(MG53/TRIM72) as a potential T-tubule repair enzyme. We find MG53, known to be involved in injury-induced
membrane vesicle trafficking and repair in striated muscle, localizes to T-tubules and is upregulated in human
failing hearts and animal models of chronic heart failure. Our preliminary data indicate MG53 possesses
apparent divergent functions in the heart, MG53 deletion of MG53 exacerbates T-tubule degeneration in
stressed hearts while exogenous MG53 overexpression promotes progressive and severe T-tubule disruption.
Interestingly, we have mapped overexpression effects to its little-studied E3-ligase domain. It is our
hypothesis, therefore, that the membrane repair versus E3-ubiquitin ligase activities of MG53 determine
cardiomyocyte T-tubule integrity and E-C coupling function during health and in disease. We have recently
generated two novel knockin animals for separately examining endogenous MG53 E3-ligase and membrane
repair functions during cardiac stress responses. We will test our hypothesis by first determining the
physiological (Aim 1) and molecular (Aim 2) actions of the MG53 E3-ubiquitin ligase, as well as its membrane
repair (Aim 3), domains in T-tubule structure and Ca2+ handling at baseline and in response to cardiac stress.
We will attribute apparently discordant ubiquitin-dependent proteolysis and membrane healing functions of
MG53 to overall T-tubule integrity, E-C coupling and cardiac remodeling processes. Understanding the
mechanisms by which MG53 facilitates T-tubule remodeling versus repair will allow us design highly targeted
and efficacious therapeutics for heart failure treatment.

Public health relevance
PROJECT NARRATIVE During heart failure, the integrity of T-tubules, specialized cell membrane structures essential for normal heart function, deteriorates making heart contraction less efficient. It is not known whether T-tubules can be repaired as a potential treatment for heart failure. This proposal examines how different activities of a potential membrane repair protein, MG53, contribute to heart disease and whether they can be leveraged toward improving T-tubule structure and overall heart function.